Referral Center - Animal models of human genetic disease

[unreadable] DESCRIPTION (provided by applicant): It is now possible to isolate genes involved in genetic diseases and understand disease mechanisms in terms of the underlying molecular derangements, and there are encouraging new prospects for therapy for genetic diseases, including somatic cell gene and stem cell therapies. The full scope of understanding and treating genetic diseases in human patients cannot be realized without authentic (gene-homologous, orthologous) animal models for studies not possible for ethical and practical reasons in human patients. Gene knockout technology in mice has provided a valuable source, but additional models are needed for studies requiring long-lived animals of larger size to be able to monitor clinical signs, and those with phenotypes more closely resembling the human diseases. A large reservoir of such diseases is present in existing inbred animal populations and can be studied with the cooperation of breeders, veterinarians, and others interested in genetic disease control. We have shown that this resource can be further utilized by providing an accessible Center to ascertain, verify, preserve, and distribute these models of human genetic disease. The objective of this project is to continue to serve as a National Referral Center to identify, characterize, and make available for research new and existing large animal models of human genetic disease. The models sought are primarily among dogs, cats, and non-human primates and involve defects in homologous gene loci having the same molecular and clinical phenotypes as in human patients. Models offering new opportunities to investigate disease pathogenesis and approaches to therapy will be emphasized in consultation with an Advisory Committee. The Center will provide the clinical, pathological, and molecular genetic studies required to discover novel animal models, including those with complex inheritance, and establish their homology with the human disorder. Verified models will be made available to other investigators at a nominal fee-for-service in the form of DNA, cells, frozen semen, and breeding stock. We will also continue to serve as a resource for normal dogs and cats and their tissues for other investigators, and we will offer a program where outside investigators can perform experiments in dogs and cats in our Resource Center facility, both on a fee-for-service basis. [unreadable] [unreadable] [unreadable]